Novel pathways regulating calcium mediated contractility in the pregnant uterus

During pregnancy, the myometrium must first remain quiescent to permit fetal growth, and then become
activated to powerfully contract and expel the mature fetus for independent life. An incomplete understanding
of the mechanisms that regulate the switch between myometrial quiescence and activation is highlighted by the
absence of effective strategies to prevent preterm delivery, the single greatest cause of mortality in children
less than 5 years of age across the globe. We recently identified the transient receptor potential vanilloid 4
channel (TRPV4) as a modulator of myometrial contractility. We showed that calcium, the most critical
determinate of myometrial contractility, can enter myometrial smooth muscle cells (mSMC) via TRPV4, a route
that is entirely distinct from L-type calcium channels. With a coordinated, multidisciplinary team, this proposal
will mechanistically explore the hypothesis that activation of TRPV4 promotes myometrial contractility
and inflammation, and is a new potential target to treat preterm labor. The discrete focus upon TRPV4 as
a novel therapeutic target for the treatment of preterm labor is highly innovative and significant, as the proposed
studies will provide essential proof-of-concept and mechanistic data to permit the development of therapies directed
against TRPV4, a target not previously addressed in the context of preterm labor. We recently showed that TRPV4
expression and localization is dynamically regulated during pregnancy, that TRPV4 promotes myometrial
contractility, and that blocking TRPV4 prolongs pregnancy in two distinct murine models of preterm labor. New
preliminary data support the hypothesis that TRPV4 also promotes myometrial inflammation, a key initiating event
in preterm labor. Thus, targeting TRPV4 may simultaneously suppress both myometrial contractility and
inflammation, a strategy likely to be more efficacious than targeting a single process, thereby representing an
innovative and unprecedented strategy. In a series of complementary aims, we will test our hypothesis using a
combination of molecular, cellular, animal, and human studies. We first plan to identify the mechanisms that
regulate TRPV4 expression and activity during myometrial quiescence and activation using wild type and
relevant knock-out mice to explore TRPV4 binding partners, activation, cell trafficking, and regulation by micro
RNAs. Second, using molecular, cellular, and murine models of preterm labor, we will test the hypothesis that
TRPV4 enhances myometrial inflammation. The third aim is designed to demonstrate fidelity between our
findings in murine models and human pregnancy. Studies in human subjects will provide essential proof of
concept and mechanistic insight into TRPV4 channel regulation and activation during pregnancy and at the onset of
labor. The completion of these studies will establish a role for TRPV4 in regulating the switch between myometrial
quiescence and activation, and provide cell- and context-specific data that can be translated into therapies that
selectively target TRPV4 in the myometrium. Together, these data will establish the TRPV4 channel as a viable,
rational and novel target to address preterm labor, the major cause of infant morbidity and mortality worldwide.

Public health relevance
Premature birth that results from preterm labor is the single greatest cause of infant mortality and morbidity in the world. Despite years of investigation, there are no reliably effective strategies to either prevent or treat preterm labor. To address this large gap in knowledge, we propose a line of investigation that will demonstrate a role for a previously unexplored target that causes uterine contraction and, if blocked, can effectively stop preterm labor, and thereby prevent premature birth.